CoPARC: Colorado Pulmonary Alcohol Research Collaborative

Project Summary
The proposed supplement will augment an established R24 Alcohol Research Resource, known as CoPARC
(Colorado Pulmonary-Alcohol Research Collaborative), that has served as a human participant and patient
biorepository supporting translational investigations at the intersection of alcohol misuse and pulmonary
disease. CoPARC is centered at the University of Colorado, and has contributed to the research programs of
established and junior investigators since 2011. Current CoPARC activities involve collection, processing, and
assays in human respiratory biospecimens. This poses an increased risk for contracting the novel severe acute
respiratory syndrome coronavirus 2 (SARS-CoV-2) infection. To address this issue, modifications to CoPARC's
existing infrastructure are necessary to continue active collaborations. Further, extending approved research
protocols to conduct investigations delineating alcohol's role in the pathogenesis of Coronavirus Disease
(COVID)-19-associated respiratory failure and the acute respiratory distress syndrome (ARDS) are planned,
and CoPARC's co-investigators have expressed unanimous support for expanded research in this area. Early
reports in patients with COVID-19-associated respiratory failure and ARDS suggest that aberrations in the
immune response influence severity of illness, contributing to multi-organ dysfunction and death. Importantly,
harmful alcohol use has been associated with dysregulated pulmonary immunity and alveolar-capillary
permeability that may explain its consistent association with severe ARDS. Nevertheless, the relationship
between alcohol use and SARS-CoV-2-related respiratory illness remains unknown. This supplement will
complement CoPARC's mission by enabling studies to delineate the impact of alcohol use on infection due to
SARS-CoV-2, including the role of alcohol use on short- and long-term outcomes in respiratory failure and
ARDS. Approximately 25% of patients hospitalized with severe COVID-19 at CoPARC's principal clinical site,
the University of Colorado Hospital, endorse regular alcohol use, and alcohol misuse appears to be increasing
across the US during the pandemic. Therefore, the role of alcohol consumption in COVID-19 disease
pathogenesis warrants additional investigation. Aims for this supplement are in line with the NIAAA's notice of
special interest to meet urgent research needs to further knowledge regarding how alcohol-associated organ
damage may complicate health outcomes in COVID-19, and include: (1) Adapt the existing CoPARC
infrastructure to safely and efficiently perform translational pulmonary investigations to understand the role of
alcohol use on SARS-CoV-2 infection, and its impact on short-term (i.e. 28 day) outcomes among hospitalized
in-patients with COVID-19-related respiratory failure and ARDS; and (2) In a cohort of ICU survivors, with and
without COVID-19-associated respiratory failure and ARDS, who are recruited for CoPARC investigations,
perform longitudinal follow up for six months following hospital discharge, including detailed alcohol use
measures and objective assessments of respiratory health.

Public health relevance
Project Narrative Alcohol misuse substantially increases the risk of developing pneumonia; further, pneumonia in this context is more severe, characterized by the need for mechanical ventilation with development of the acute respiratory distress syndrome (ARDS), and higher mortality. Although coronavirus disease 2019 (COVID-19) has been associated with development of severe pneumonia and ARDS, the role of alcohol misuse in disease pathogenesis is unknown. This R24 Resource supplement will enable performance of both short- and long- term investigations to establish the impact of alcohol misuse on COVID-19 risk and outcomes.